Inhibiting neovascularization for corneal wound healing

Project Summary
The healthy cornea is an avascular tissue which is a requirement for optical clarity and good vision. Diseases
in which the optical clarity of the cornea is lost are the third most common cause of blindness worldwide.
Various disease conditions, such as corneal injury, can result in inflammation and the pathological ingrowth
of vessels into the cornea, a process known as corneal neovascularization (CNV). Prevention of vascular
ingrowth is imperative in maintaining the health and transparency of the cornea. We have previously
demonstrated that MG53, a tissue repair gene, can promote corneal wound healing in both the epithelium
and stroma. We recently discovered that MG53 can modulate corneal inflammation and vascularization. An
approach that can functionally target multiple steps in corneal wound healing may have the potential to
significantly improve healing outcomes, leading to novel therapeutic options. MG53 is present in the human
tear film, aqueous humor, and corneal epithelial cells, supporting its potential function in corneal homeostasis
and wound healing. We show that genetic ablation of MG53 leads to pronounced corneal inflammation and
neovascularization as compared to wild type littermates. Using in vivo corneal injury models, we find that MG53
promotes corneal transparency by reducing acute inflammation and post-injury vascularization. Biochemical and
animal studies revealed that pyroptosis, a cytolytic cell death, is a novel pathway involved in post-injury CNV, as
observed in gasdermin D, a key molecule of pyroptosis, knockout corneas which were resistant to injury-induced
CNV. Further, MG53 can inhibit pyroptosis by interacting with gasdermin D, preventing its activation. In vivo
corneal wounding experiments revealed corneal pyroptosis followed neutrophil infiltration. Antibody depletion of
neutrophils completely abolished post-injury pyroptosis, suggesting infiltrating neutrophils undergoing pyroptosis
trigger secondary corneal injury and CNV. Indeed, when irradiated WT recipient mice received bone marrow
(BM) transplantation from GsdmD-/- mice, they displayed enhanced corneal healing as compared to mice that
received BM from WT mice. Experiments outlined in this project are centered on testing the hypothesis that
neutrophil pyroptosis is a key pathway that mediates corneal inflammation and CNV following injury; MG53 can
inhibit pyroptosis via preventing activation of GasdmD, thus rhMG53 can be used as an effective means to treat
corneal injury. We envision that MG53 can be applied to promote corneal healing and prevent neovascularization
after injury. The outcome of this research shall have significant translational value in developing potentially
effective therapies to treat corneal injury and neovascularization associated with corneal disease.

Public health relevance
Project Narrative Corneal wounds are complicated and common consequences of surgery, trauma, burns, and oxidative injury; inflammation and corneal neovascularization from corneal injuries are a leading cause of vision loss worldwide. There are currently no effective treatment options available to corneal neovascularization associated with injuries and development of new therapeutic options would benefit a large number of people. This project will clarify the role of a repair molecule in the cornea and conduct proof-of-principle studies for mitigating inflammation as well as neovascularization to treat complicated corneal wounds.